Cancer training

The overall goal of the Cancer Training Program (CTP) is to develop programs that will facilitate both faculty and graduate student training and career development In cancer research. Specifically, we will: 1) Implement a 12-month Health Disparities Research Training Program (HDRTP) targefing post-doctoral fellows and junior faculty with three career training tracks (Community-Based Participatory Research, Cancer Control and Populafion Science, and Basic Science in Cancer Research); 2) Implement a Summer Cancer Research Training Program (SCRTP) targeting graduate students, to introduce students to the cancer research field and provide them with basic knowledge about cancer health disparities and methods to address these disparities; 3) Provide extended training to graduate students who have excelled in the SCRTP through the implementation of a year-long Cancer Research Fellows Program; and 4) Improve the integration of all levels of training (graduate students, post-doctoral fellows, and faculty) and promote the CTP as a professional development resource through a Web-based Resource Center, Alumni Program, and symposia,

Public health relevance
The Cancer Training Program (CTP) is highly relevant to the objecfives ofthe Partnership. One ofthe priorities ofthe Partnership is to develop a cadre of well-trained investigators who will seek to understand the root causes of cancer disparifies among racial/ethnic minorifies and socioeconomically disadvantaged populations and test strategies to address and eliminate these disparities. By targeting three levels of cancer research investigators—graduate students, post-doctoral fellows, and faculty (including junior faculty and transitional faculty)—the Training Program aims to increase the number of minority investigators engaged in cancer research as well as the number of non-minority investigators engaged in cancer research with minority and socioeconomically disadvantaged populations. Through this work, we strive to make cancer disparities history and improve the health of minorities and disadvantaged populafions throughout the Southeast and the nafion. The CTP is critical component integrated with the Partnership's other programs. It links with the Cancer Research Proqram throuah the training of junior pilot project invesfigators, facilitafing their career development, and offering them seminars and scholarly enrichment events. CTP scholars and students have the opportunity to work on community-based research projects through the Cancer Outreach Prooram. The CTP integrates the Bioethics Shared Resource and the Biostatisfics Shared Resource into its training components. By providing workshops and online courses in these two areas and emphasizing the importance bioethics and biostafisfics in lectures and discussions, the CTP develops greater awareness of how bioethics impacts research decisions and acfions, and how crifical biostatistics is throughout the research process. The CTP is also linked with the Cancer Education Program through the courses at TU, namely Foundations of Cancer Biology, Biosciences Research and Ethics (both established and implemented underthe P20 grant), and the Health Disparifies course launched in 2007-2008 school year. At MSM, a cancer track existed in the Preventive Medicine Residency program. During the proposed funding period, other graduate students at MSM (MPH, MSCR, and MD) will have access to cancer education through a recently developed, NCI R25-funded curriculum. Thus the CTP works together with all programs and cores in a cohesive effort to reach the overall Partnership goals.